PREP at University of Georgia

The University of Georgia (UGA) proposes a renewal of PREP@UGA that builds on the program’s successes
to date and continues to advance diversity of the biomedical research workforce. Diversity of the biomedical
research workforce is critical to the success of the NIH mission and necessary for research innovation,
translation, and justice. However, ongoing, difficult work is needed to advance diversity within and beyond
UGA. PREP@UGA has a successful record of recruiting, supporting, and preparing postbaccalaureate
students in pursuing further education and careers in biomedical research. To date, PREP@UGA has trained
53 Scholars with 87% matriculating into biomedical research PhD programs at research-intensive universities.
Seven PREP@UGA alumni successfully completed doctoral training and are now in Postdoctoral Fellowships
in academia and government or working in industry or academia. Thirty-three PREP@UGA alumni are in good
standing in their PhD programs. The program is well-positioned to continue this important work because of its
close alignment with UGA’s Diversity and Inclusive Excellence and 2025 strategic plans, which have catalyzed
changes in institutional policies and practices to address systemic issues that have limited diversity. In this
renewal, PREP@UGA will (1) continue to use a multi-pronged approach to recruit diverse cohorts of six
postbaccalaureate Scholars who identify as underrepresented and/or as having a disability; (2) continue to
engage Scholars in intensive research training with quality mentorship; (3) enhance the collective and
individualized professional development for Scholars; and (4) enhance Scholars’ networking in ways that
enable them to bring their whole selves to their research, educational, and career pursuits. We propose three
programmatic enhancements in response to results from evaluation and findings from education research.
First, we will strategically expand the pool of faculty mentors so that Scholars can participate in research that
more fully represents the disciplinary breadth of biomedical research on campus. This change has the added
value of increasing the racial, ethnic, and gender diversity of PREP@UGA’s pool of quality research mentors.
Second, we will establish a cadre of career mentors who are diverse in terms of their biomedical research
discipline, career path, and personal characteristics (e.g., race, ethnicity, gender, ability status) for additional
support and advice for navigating academic research and career pursuits. Finally, we will add value to the
current, effective professional development activities by adding two modules. The first will support Scholars in
building their knowledge and skills to understand and evaluate statistical analyses in published research. The
second will introduce Scholars to notions of community cultural wealth and funds of knowledge to affirm the
strengths they bring to the biomedical research endeavor and support them in using science for social justice.

Public health relevance
Diversity in the biomedical research workforce elevates scientific innovation and impact to levels necessary to impact human health and well-being. Underrepresented minorities and persons with disabilities face systemic issues that impede their research training, which limits this diversity. This renewal of PREP@UGA builds on the program’s successes to date and continues to advance the diversity of the biomedical research workforce by recruiting recent post-baccalaureate underrepresented minority and disabled students and providing research-intensive training and professional development to facilitate their transition to and success in biomedical PhD programs.